Renewal of Summer Research Program

Abstract:
Our demonstrated successful Office of Research and Development (ORD) funded Veteran
Administration South-Central Appalachian Network Research Development (VA SCAN-RD)
seeks to renew Summer Research Program (SRP) funding to increase rural 1) clinician
researcher diversity and 2) expand VA research capacity across the South-Central Appalachian
(SCA) region and other rural living Veteran areas. The two goals clearly address the existing
inequity in rural Veterans enrolled in clinical research trials. This enrollment inequity may
inaccurately direct optimal care practice guidelines as rural Veteran needs are not adequately
included, and these individuals hold different health care need facilitators/barriers.
The Western North Carolina VA Health Care System (WNCVAHCS), serving over 67,000
veterans across a 23-county catchment area partnered with Salisbury (110,000 central North
and South Carolina Veterans) and James H. Quillen VAMCs (170,000 Veterans in a 41-county
area of northeastern Tennessee, western Virginia, and southern Kentucky) is actively building
community partnerships and academic affiliations to strengthen outreach and research
capabilities. This program aims to transform research efforts across South-Central rural
Appalachia and rural living Veteran regions by engaging potential and existing clinician
researchers in a systematic approach to in-depth VA research understanding.
During our 3-year Office Research Development funded pilot program we enrolled 36 year one
and 7 year two SRP participants: undergraduates; graduate students; professional students;
employees; and Veterans. We will continue to recruit undergraduate, graduate, post-doctoral
participants and employees from the South-Central Appalachian and other rural living Veteran
regions to participate in quality self-directed adult learning focusing on expanding access to
rural and underserved Veteran populations. SRP participants asynchronously engage in the 8
module, online curriculum with two required weekly meetings, a cohort group meeting and
mentor/mentee group meeting. Our experienced mentor/mentee teams provide research,
career, and VA research content support while the SRP multi-discipline cohort members
broaden practice and career pathway discussion. Given the travel distances and time and
financial difficulty to be onsite this innovative, virtual SRP plan is meeting participant, mentor,
and site needs and capabilities.
The Executive Medical Center Directors of Charles George, W.G. (Bill) Hefner and James H.
Quillen VAMCs, recognize the program potential to diversify and create opportunities for
learning and development by empowering the workforce in the SCA and other rural regions,
enhance research capabilities, improve healthcare outcomes, and ultimately facilitate optimal
Veteran healthcare. Based on our demonstrated successes we seek Summer Research
Program renewed 3-year funding to continue a pivotal role in transforming research and
educational endeavors in the South-Central Appalachian and other rural regions. Through our
ongoing collaborative efforts, we foster clinician-researcher diversity, empower the workforce,
and positively impact VHA research services.

Public health relevance
Our successful 3-year Office of Research and Development (ORD) funded pilot, Veteran Administration South-Central Appalachian Network Research Development (VA SCAN-RD) seeks Summer Research Program (SRP) renewed funding to foster rural 1) clinician researcher diversity and 2) expand VA research capacity across South-Central Appalachia (SCA) and other rural living Veteran areas. Noting rural Veterans clinical trial enrollment Western North Carolina VA Health Care System (WNCVAHCS), Salisbury, and James H. Quillen VAMCs (serving > 350,000 rural living Veterans) combined in VA SCAN-RD, an asynchronous adult learning research curriculum. Establishing community partnerships and academic affiliations we are transforming research efforts across SCA and rural living Veteran regions by engaging clinician researchers in a systematic approach to in-depth VA research understanding.